Viral infections and celiac disease pathogenesis

PROJECT SUMMARY/ABSTRACT
The central goal of the proposed research is to determine mechanisms by which viral infections lead to loss of
tolerance (LOT) to oral antigen and induce celiac disease (CD) and to design strategies to prevent virus-
induced LOT and CD onset. Viral infections are increasingly recognized as contributing factors in the
pathogenesis of autoimmune inflammatory diseases. However, little is known about the biological features that
enable a virus to provoke inflammatory tissue injury. CD is a T cell-mediated intestinal disorder with an
autoimmune component characterized by an inflammatory anti-gluten immune response that occurs
exclusively in gluten-exposed persons with HLA DQ2 or DQ8 alleles. Approximately 45% of the U.S.
population expresses DQ2 or DQ8, yet only 1% of the population develops the disease, indicating that
additional factors contribute to disease induction. Reoviruses are human dsRNA viruses recently linked to CD.
These viruses infect the murine intestine and can be genetically manipulated to identify viral determinants of
autoimmune host responses. We discovered that reovirus strain T1L abrogates tolerance to dietary antigens
including gluten using a pathway dependent on IRF1, whereas strain T3D-RV does not. Induction of protective
immunity to T1L occurs by a mechanism distinct from that required for immunopathology. We propose to
enhance an understanding of how viruses influence the development of autoimmune inflammatory
disorders and prevent CD by identifying virus and host factors that influence LOT to dietary antigen
and defining strategies to block virus-induced LOT and CD development. To achieve this goal, we have
designed three well-integrated specific aims. In Specific Aim 1, we will define the viral determinants and
associated host pathways responsible for LOT using T1L x T3D-RV reassortant viruses and engineered viral
mutants to define functional domains of protein products responsible for LOT. We will elucidate mechanisms
underlying IRF1-mediated TH1 immunity following reovirus infection using mice lacking IRF1 or IRF1-inducing
factors in specific cell types. In Specific Aim 2, we will define the effect of T1L and T3D-RV infection on the
composition of microbial communities. We will also determine the contribution of the intestinal microbiota to
reovirus-induced LOT by assessing LOT in antibiotic-treated and germ-free mice with and without defined
microbiota. In Specific Aim 3, we will define the temporal relationship of T1L infection and gluten introduction
on LOT using mice engineered to express the human DQ8 risk allele. We will test whether inoculation with
inactivated or attenuated reovirus prior to gluten introduction prevents LOT mediated by T1L. This project
extends a productive collaboration of internationally recognized PIs with complementary expertise in CD,
mucosal immunology, and virology. Knowledge gained through these efforts will enhance an understanding of
how viral infections lead to the development of gastrointestinal inflammatory disorders and foster new
strategies to prevent CD in genetically vulnerable individuals.

Public health relevance
PROJECT NARRATIVE Celiac disease is a gluten-induced inflammatory disorder of the small intestine for which no non-dietary therapy exists at present. 45% of the U.S. population carries the disease predisposing DQ2 or DQ8 allele, yet < 1% of the population develops the disease, suggesting a role for environmental triggers other than gluten. Loss of oral tolerance to gluten is required for development of celiac disease, and our recent study has demonstrated that reovirus infection triggers development of celiac disease. We seek to advance our understanding of how viruses induces loss of oral tolerance to dietary antigens and to define strategies to prevent virus-induced loss of oral tolerance to gluten and celiac disease development.